Biophysical muscle modeling software for enhancing open science

Project Summary
The goal of this supplement is to enable a large community of musculoskeletal modeling researchers to easily
access and robustly use validated biophysical muscle models generated by the parent grant to generate
multiscale simulations of muscle function. To date, there are extremely few musculoskeletal movement
simulations (<5) that use biophysically-based muscle models; those that are available are not easily
generalizable for use by other researchers. Research from the parent grant establishes new, experimentally-
validated formulations of biophysical muscle models to reproduce novel features of muscle force generation for
understanding sensorimotor function in behavioral and clinical contexts. We use the MyoSim software platform
developed by Co-I Campbell to demonstrate the superiority of biophysical muscle models over standard
phenomenological models used in musculoskeletal simulations of movement. However, it will be difficult for
other researchers to easily implement these models in other movement contexts. This supplement will enable
broader dissemination of our ongoing and prior research, to enhance open science and accelerate progress in
multiscale modeling in the muscle, cardiac, and musculoskeletal modeling communities. Software
Supplement Aim 1 will improve, standardize, and document MyoSim software so that it can be easily
integrated with other multiscale simulations on scientific computing platforms such as MATLAB and Python.
Software Supplement Aim 2 will integrate MyoSim muscle models with OpenSim, an NIH-funded
musculoskeletal simulation platform with ~70,000 users. The supplement will also support virtual tutorial
workshops aimed at muscle modeling researchers including muscle and cardiac researchers, including those
using finite element models, and the OpenSim musculoskeletal modeling community. Creating open,
generalizable and extensible MyoSim functionality for multiscale modeling will increase scientific innovation
and enhance open science in musculoskeletal research, and dramatically increase the MyoSim user base.

Public health relevance
Narrative This supplement will develop state-of-the art software for predicting muscle function to be shared widely with researchers in the musculoskeletal and cardiac research fields. The open and extensible platform will enable new research communities to accelerate innovative research for understanding and treating cardiac, musculoskeletal, and neurological disorders.